Tri-Institutional TRAC Clinical Science Core

The Clinical Science Core: The role of the Clinical Science Core in the Tri-Institutional TB Research
Advancement Center (Tri-I TRAC) is to provide new investigators (NIs), new to TB (N2TB) investigators and
other TRAC investigators access to existing clinical TB research expertise, resources, and infrastructure. The
goals of the Clinical Science Core are the same as the overall TRAC and are to increase the number of new
investigators in TB and to foster innovative multidisciplinary TB research. The activities of the core will
primarily concentrate on our partner site GHESKIO in Port au Prince, Haiti, which is an established NIAID TB
clinical trials unit with 39 years of TB research collaboration with the Tri-I partners. We will also support TB
research collaborations at Weill Bugando School of Medicine in Mwanza Tanzania which is also an NIAID
supported TB research site. The Clinical Science Core will provide mentorship in clinical TB research to new
investigators, provide technical expertise in clinical TB research including study design, data management,
clinical laboratory, and biostatistics. The core will provide access to TB clinical cohorts and a large well
curated biobank of clinical samples from Haiti. Cohorts include families with multiple members with TB and
their contacts, longitudinal treatment cohorts with well characterized post-treatment recurrences, early
bacteriacidal activity (EBA) TB trials with intensive monitoring of Mtb quantity in sputum, pediatric cohorts
with children under 5 years of age with active TB and controls without TB, and a 3,000 person population
based community cohorts with incident TB cases. Biobanked samples include whole blood, serum, peripheral
blood mononuclear cells, urine, sputum, stool, and host DNA. We also have a biobank of all 14,360 Mtb
clinical isolates collected at GHESKIO from all new TB cases diagnosed over ten years with associated
demographic and clinical data. NIs, N2TB investigators and others will have access to these resources. NIs
who receive a Developmental Project Award will also receive from the Clinical Science Core a complement of
mentorship, career development, technical experts and access to clinical cohorts and biobanked samples. This
full package for NIs is the Training to Independence Pathway. The goal is to help NIs secure an independent
faculty position and their first R01. NIs, N2TB, and experienced investigators may also apply to the Clinical
Science Core for more targeted support which includes technical experts and access to cohort and biobanked
samples. This is time limited (<6 months) targeted core support to foster new multidisciplinary research. The
Clinical Science Core will work synergistically with the other TRAC Cores to achieve our overall TRAC goals to
have 25 NIs successfully compete for a TB related NIH R01 and transition to independence and to attract at
least 5 N2TB investigators to TB science over 5 years. Half will be women and at least 20%
underrepresented minorities. We will also initiate new lines of translational research to address the five
NIAID priorities in TB science with the ultimate goal of ending morbidity and mortality from TB world-wide.